The Wisconsin State Laboratory of Hygiene’s Proposal to Add to the Capability and Capability of the U.S. Food and Drug Administration’s Food Emergency Response Network

PROJECT SUMMARY/ABSTRACT The Wisconsin State Laboratory of Hygiene (WSLH) is Wisconsin's public and environmental health laboratory. As part of the University of Wisconsin–Madison, the WSLH is committed to exploring new ideas which benefit the state, the nation and the world. The Radiochemistry Unit of WSLH offers a wide range of radiological testing services to maintain its testing capability and capacity to rapidly and accurately respond to food emergencies under the FDA FERN Radiological Cooperative Agreement Program. Instrumentation used to support screening and confirmatory testing under this program include gamma and alpha spectrometers, gas proportional counters, and a liquid scintillation counter. A cadre of scientists is qualified to sustain approved FDA FERN CAP methodologies. The lab is certified and routinely inspected by the Environmental Protection Agency and a complete Quality Assurance and Quality Control Program is maintained, assuring high quality results. WSLH will continue to use FERN FDA Radiological Cooperative Agreement funding to strengthen and improve the lab's capability and capacity to rapidly and accurately identify radiological contaminants in food and environmental samples. The WSLH also aims to improve the lab's existing Strontium?90 in milk method, validate additional food matrices with existing methods and develop a soil fusion procedure to enhance its capability. The WSLH staff will attend and contribute to annual network meetings and serve on FERN committees and contribute to special projects offered by the FERN NPO. The WSLH will furthermore maintain FERN methodologies and agrees to actively participate in proficiency testing and exercise offerings. In case of a large?scale radiological event, WSLH will assist the FDA and other network partners with performing needed testing and provide electronic data reporting as directed by the FERN NPO. The WSLH seeks to provide method development and method validation for FERN methodologies in collaboration with network partners.

Public health relevance
PROJECT NARRATIVE This grant will be used to increase the Nation's capacity to analyze food in the event of a radiological emergency. This grant will also be used to make improvements in the planning and execution of an emergency strategy.